The role of tyrosine metabolism in tuberculosis pathogenesis

ABSTRACT
Tuberculosis (TB) is a leading cause of death globally. It remains unclear why only a small number of
Mycobacterium tuberculosis (Mtb)-infected individuals progress to TB disease. Mtb is known to rewire the
immunometabolism of infected monocyte-derived phagocytes following acute infection. Consistently, systemic
shifts in metabolism are a hallmark of TB pathogenesis, thus highlighting metabolism as a possible target for
intervention. Tyrosine, an aromatic amino acid, is shown to accumulate in the serum of TB patients compared to
healthy controls. However, it is unknown whether and how defects in tyrosine metabolism could mediate
susceptibility to Mtb infection or risk of TB progression. We found that Mtb infection of primary human myeloid
cells downregulates expression of Fumarylacetoacetate hydrolase (FAH); a key enzyme involved in tyrosine
catabolism. We also identified a genetic variant associated with lower FAH expression in monocyte-derived
dendritic cells (DCs) in Peruvians who progressed to TB. We previously showed accumulation of tyrosine in the
plasma of prospectively enrolled African household contacts of TB patients who progress to TB compared to
non-progressors, consistently with a role for tyrosine catabolism in protection from TB. Importantly, knocking out
FAH in murine macrophages increased their susceptibility to Mtb infection, suggesting that impaired tyrosine
metabolism by FAH may drive loss of Mtb control. Mechanistically, tyrosine metabolites may contribute to the
altered metabolic states of Mtb-infected cells. We hypothesize that Mtb-mediated interference with tyrosine
metabolism has evolved as a mechanism of virulence and could mediate progression to TB disease. We
propose a series of in vitro and in vivo experiments to define the requirement for host tyrosine metabolism
following Mtb infection. We will target FAH using gene editing of primary human myeloid cells to test whether
this key step in tyrosine metabolism is required to contain Mtb infection. We also plan to adoptively transfer fah-
deficient fetal liver cells into TB-susceptible mice to test the requirement for tyrosine metabolism in hematopoietic
cells to control Mtb infection in vivo. Secondly, we will define the metabolic consequences of FAH deletion in
Mtb-infected monocyte-derived DCs and macrophages using metabolic flux experiments, and metabolite
complementation of Mtb-infected FAH-deficient cells. Finally, we will leverage samples and datasets from two
independent cohorts of different TB disease states. The first is a cross-sectional Peruvian cohort of TB patients
and Mtb-infected and uninfected contacts, where we bio-banked plasma samples for targeted analysis of tyrosine
metabolites by high resolution mass spectrometry. The second is a previously described longitudinal cohort of
African household contacts of TB patients followed for 2 years, where we also obtained genotyping data to
explore the impact of polymorphisms in select metabolic genes on expression of tyrosine metabolites. Defining
a causal association between impaired tyrosine metabolism and TB risk would motivate for future trials to
repurpose existing agents to treat inborn errors of tyrosine metabolism as host-directed treatments against TB.

Public health relevance
NARRATIVE Tuberculosis (TB) remains a leading cause of death from infectious diseases globally. Understanding why some infected individuals develop disease and others do not is paramount to developing preventative treatments. We discovered an unexpected association between TB susceptibility and inhibition of tyrosine metabolism, which could be leveraged as a novel target for preventative therapy against TB progression.